Using Novel Labeling to Improve Public Understanding of Nicotine in Electronic Nicotine Delivery Systems (ENDS): Nicotine Concentration and Nicotine Flux

Project Summary
Use of Electronic Nicotine Delivery Systems (ENDS) can have positive and negative effects on public health.
Ideally, people who smoke would switch to ENDS, and vulnerable populations like youth would avoid ENDS
altogether. Yet, most adults who use ENDS also smoke, and ENDS have been the most popular nicotine
product among youth since 2014. Effective informational labels for the nicotine strength of ENDS could help to
address these problems. For smokers who want to switch to ENDS, easily selecting a product with sufficient
nicotine to facilitate a complete switch is critical. For youth, informative labels may deter ENDS uptake, use of
high-nicotine ENDS, and development of nicotine dependence. The FDA requires nicotine concentration labels
on ENDS, typically in mg/mL or percent, but neither youth nor adults understand these metrics. We previously
pilot tested new nicotine concentration labels that improved ENDS users' ability to interpret the strength and
addictiveness of nicotine in ENDS. Here, we propose to extend our work to develop two labels: 1) a nicotine
concentration label that could replace all current FDA-required ENDS nicotine concentration labels, and 2) a
novel, potentially more informative label for nicotine emissions (“flux”) from popular closed-system devices like
Vuse and JUUL. In Aim 1, we will refine our piloted nicotine concentration label by re-anchoring the nicotine
strength categories on the label (e.g., medium, high) to the nicotine content in cigarettes. We also will develop
nicotine flux labels for closed-system ENDS, which have fixed, calculatable nicotine emissions; are the most
popular device type; and are the only device type to receive FDA approval for sales in the United States. Flux,
the rate of nicotine emissions from ENDS, better approximates nicotine delivery than concentration alone. We
will employ qualitative methods (i.e., expert feedback, focus groups) to identify the optimal scaling for our
concentration label and to determine key features for inclusion on our flux labels. In Aim 2, we will compare the
mg/mL market label (the top-performing market label from our prior work), optimized nicotine concentration
label, and flux labels. We will survey 2,000 youth and adults who use ENDS, cigarettes, or no tobacco products
to compare the ability of our new labels to accurately convey ENDS nicotine strength relative to current market
labeling and to each other. We also will assess perceived addictiveness, perceived label utility, and product
use intentions. We expect the new concentration and flux labels to more accurately convey ENDS nicotine
strength than mg/mL alone. We also expect the new labels to better convey information about addictiveness, to
be rated as having more utility than mg/mL, to decrease use intentions among never users, and to increase
intentions to use ENDS in a quit smoking attempt. Project findings will provide the FDA a superior alternative to
current nicotine concentration labels for all ENDS and will indicate if nicotine flux labeling has added benefit for
the most popular ENDS device type: closed-system ENDS. In sum, the proposed project will increase public
understanding of nicotine concentrations of all ENDS and nicotine emissions from closed-system ENDS.

Public health relevance
Project Narrative Product labeling for the nicotine concentration of liquids used in Electronic Nicotine Delivery Systems (ENDS) currently is not sufficiently informative to the public, so this project will improve upon FDA-required labeling of ENDS nicotine concentration by producing an optimized nicotine concentration label that is linked to an objective scaling metric: the nicotine content of combustible cigarettes. We expect our new concentration label to improve understanding of the nicotine strength and, secondarily, addiction potential of ENDS liquids among youth and adults. The project also will generate data on the utility of labeling nicotine emissions from closed- system ENDS (i.e., non-refillable pod/cartridge-based devices and disposables) via nicotine flux, a complex but potentially more informative index of nicotine from closed-system ENDS that better approximates nicotine delivery than does liquid nicotine concentration alone.